Epigenetic mechanisms of cochlear damage and repair

PROJECT SUMMARY
Pathogenic variants of human CHD4 cause Sifrim-Hitz-Weiss disease, a neurodevelopmental disorder
associated with hearing loss. CHD4 is a chromatin-remodeling protein expressed in hair cells and supporting
cells of the cochlea. We hypothesize that CHD4 maintains cell identity in the cochlea. We ablated CHD4 in hair
cells and showed gradual hair cell degeneration along with epigenetic changes in supporting cells. Aim 1 tests
if CHD4 ablation alters gene regulatory networks and changes hair cell identity to cause hair cell death. Aim 2
examines whether increased Wnt signaling changes the chromatin accessibility of supporting cells. Aim 3
investigates if CHD4 loss in supporting cells decreases DNA methylation at hair cell gene promoters to make
supporting cell identity malleable. The proposal provides mechanistic insights into hair cell maintenance and
regeneration, which can be repurposed to treat a wide spectrum of hearing loss.

Public health relevance
PROJECT NARRATIVE Pathogenic variants of the human CHD4 gene cause Sifrim-Hitz-Weiss disease, a neurodevelopmental disorder associated with hearing loss. CHD4 is a chromatin-remodeling protein that maintains the epigenetic landscape of a cell. The proposal aims to understand how loss of CHD4 results in epigenetic changes that cause hearing loss. Understanding the function of CHD4 also offers insights into hair cell maintenance and regeneration, which is broadly applicable for repairing cochlear damage.